Assembly and Dynamics of Molecular Machines in Genome Maintenance

ABSTRACT
Efficient genome maintenance is a double-edged sword. Accurate repair of DNA lesions and damaged
replication forks promotes genome stability, which is a key to avoiding cancer, aging and neurodegenerative
diseases associated with DNA repeat expansion. The same mechanisms that maintain genome integrity in
healthy cells, allow cancer cells to acquire a more aggressive character and develop resistance to radiation and
chemotherapy. Untimely deployment and/or dysregulation of the DNA repair machines may further destabilize
the genome or may result in the accumulation of geno- and cytotoxic repair intermediates. Significant gaps
remain in our understanding of the molecular events that funnel the intermediates of otherwise accurate repair
into “rogue”, genome-destabilizing mechanisms.
This research program emphasizes the molecular and structural mechanisms by which the intermediates of DNA
metabolism bound by Replication Protein A (RPA) are channeled into DNA repair, protection of DNA replication
forks, homologous recombination, DNA damage tolerance and signaling.
Our central hypothesis is that the activities of the RAD51 recombinase, the ssDNA-binding protein RPA,
recombination mediators BRCA2 (in human) and Rad52 (in yeast), and DNA repair helicases are finely tuned by
a variety of factors, which include posttranslational modifications, interacting partner proteins, specific DNA
structures and DNA lesions. These factors affect the protein configurational dynamics and critical protein-protein
interfaces. Understanding how the protein plasticity and kinetics of assembly of the macromolecular machines
of DNA repair will show us new ways to selectively manipulate the activities of RAD51, RPA and multifunctional
DNA helicases and polymerases in DNA replication and repair.
We are leveraging and building the tools of single-molecule biochemistry, biophysics, structural and chemical
biology. Our unique perspective on the formation, activities and regulation of the nucleoprotein complexes
orchestrating genome maintenance is rooted in our ability to visualize microscopic configurational dynamics of
and sort individual human DNA repair proteins with their native posttranslational modifications, and to probe and
separate activities associated with different surface-tethered proteins and nucleoprotein complexes at the single-
molecule level. Our goal is to provide an entirely new outlook on how the cell balances the assembly and activities
of the molecular machines that can repair, but also destabilize, the genome, and to be able to alter this balance
with new chemotherapeutics targeting cancer and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Molecular machines that function in DNA repair maintain integrity of the genome by promoting faithful repair of the most genotoxic DNA lesions and faithful genome replication. Defects in their regulation can lead to genetic instability and chromosomal rearrangements causing cancer, aging, and diseases associated with progressive expansion of repeated sequences (including Huntington's disease, myotonic dystrophy and Fragile X syndrome). Understanding the fundamental molecular mechanisms of how DNA repair is regulated and its dysregulation will reveal features, which can be exploited in developing novel therapeutics.